Research Programming Module

The Research Computer Programing Core Module will provide software design and development
services to support and advance innovative vision research. The module will provide project
management of custom research software and will develop or supervise development of software
when the scope or sophistication of the project goes beyond what an individual investigator's lab
can undertake. The principal developer works closely with investigators to clarify and document
the software requirements, taking into consideration their unique needs regarding the user
interface and data management, as well as technical requirements of the application. The module
also will provide consultation and assistance regarding algorithms and debugging, data
management, and communication with vendors on technical issues for Core investigators, their
collaborators, newly hired investigators, research staff and graduate students who develop their
own software. The Core Module will be supervised by Vallabh Das, PhD, Benedict Pitts Professor
of Optometry and Vision Science, with a joint appointment with Biomedical Engineering. Dr. Das
is an NEI-funded investigator (13 yrs) who has extensive expertise in software development for
neurophysiological investigations of the oculomotor system.